Hand Tremor Compensation Approach for Touch Screens

Project Summary/Abstract
The proposed project relates to the development of an innovative technological intervention to improve the
usability of smartphones and other electronics devices for persons suffering from hand tremor. Given the
ubiquitous presence of such electronics technology, our proposed intervention aims to significantly improve the
quality of life of individuals afflicted with action tremors. The proposed intervention is exclusively a software
solution that compensates for tremor to allow inputs. It does not require users to procure, carry, wear or maintain
any specialized tools or hardware and therefore will bring no known risk to the patients. There is substantial
interest in nonpharmacological therapies and functional rehabilitation for patients with tremor that respond poorly
to medication and are not surgical candidates. The phase I project will develop a prototype solution and evaluate
its usability and acceptability in persons with hand tremor in a proof-of-concept trial at Mayo Clinic.

Public health relevance
Project Narrative Hand tremor affects approximately 4% of the population aged 65 and over. Individuals suffering with tremor often report significant psychological symptoms including anxiety, depression and dissociation. Tremor affects common activities of daily living including writing, using a drinking glass, handling cutlery, and using electronics (texting/typing and using smartphones).